University of California San Diego REACH Center for Translational Science on Whole Person Health (UCSD REACH)

The University of California San Diego REACH Center for Translational Science on Whole Person Health
(UCSD REACH) creates partnerships between UC San Diego and accredited complementary and integrative
health (CIH) institutions to drive the advancement of translational science on whole person health, an NCCIH
priority. The proposed UCSD REACH leverages the traditional knowledge and clinical experience of CIH
partner institutions in whole person health practices, and pairs them with the cutting-edge scientific expertise
and resources of UC San Diego, with additional expertise, mentoring, and collaborative opportunities with
faculty scientists from multiple participating University of California campuses. The proposed Center creates a
bi-directional research generator informed by the CIH expertise of partnering institutions coupled with the
robust research capacity of a Tier 1 academic research university at a scale that has never before been
accomplished. The Directors of UCSD REACH each bring complementary track records of leadership on NIH-
and NCCIH-supported research projects and training programs (T32, T90/R90, and K), plus over two decades
of experience collaborating with CIH institutions. The UCSD REACH Center will meet the following specific
aims: 1) Build the research capacity at CIH partner institutions; 2) Invest in fostering the research careers of
partners’ faculty through UCSD REACH Scholars--a CIH translational scientist training and mentoring program
to accelerate the Scholars’ research activities and competitiveness; 3) Support pilot projects and generate
competitive extramural grant proposals resulting from collaborative development of promising research ideas
into rigorous study designs; 4) Evaluate UCSD REACH on formative and summative metrics including a
demonstrated commitment to diversity, equity, inclusion, and access. The UCSD REACH will provide access to
the wealth of resources at UC San Diego, which is nationally ranked #5 in NIH funding among public
universities and #13 overall. Resources across UC San Diego and multiple UC campuses will be available for
this initiative in order to elevate the research capacities of our partners. Resources include documented
commitments from the UCSD CTSA-funded Altman Clinical and Translational Research Institute, along with
faculty, mentors and advisors from UC Irvine’s Samueli Integrative Health Institute, the Center for Integrative
Medicine at UC Davis, the UCSF Osher Center, and UCLA’s Geffen School of Medicine. The six inaugural
partners include accredited CIH institutions with programs in physical therapy, osteopathic manual medicine,
naturopathy, chiropractic, and East Asian medicine, with plans for expanding partnerships to a total of 16
institutions over the funding period, and producing a total of 28 trained Scholars. The scientific framework
focusing on Translational Science on Whole Person Health sets the proposed UCSD REACH apart, and allows
partnering institutions and their faculty to be in lockstep with new developments in science through access to
cutting-edge tools and resources, and become active partners in innovative science while building capacity.

Public health relevance
The UCSD REACH Center for Translational Science on Whole Person Health (UCSD REACH) will collaborate with accredited complementary and integrative health partnering institutions to increase their research capacity and drive the development of rigorous whole-person health science. The proposed UCSD REACH leverages the traditional knowledge and experience of CIH institutions in whole-person health practices, paired with the cutting-edge scientific expertise and substantial resources at UCSD, with additional expertise and collaborative opportunities from the UC-Centers for Integrative Medicine and Health across multiple UC campuses. The resulting UCSD REACH will function to meet the following specific aims: 1) Build the research capacity of CIH partners by providing infrastructure, training, and fund management support; 2) Invest in fostering the research careers of CIH partner institution faculty, mentoring them as UCSD REACH Scholars and providing CIH-oriented training and access to research resources focused on a) best practices and methods in clinical research and b) cutting edge translational sciences applied to whole-person health (e.g., microbiome, multi-omics, epigenetics, machine learning, digital health, etc.); 3) Support pilot projects and generate competitive extramural grant proposals resulting from collaborative development of promising research ideas into rigorous study designs; and 4) Evaluate the UCSD REACH on both formative and summative measures of success.